Advanced Training in Environmental Health Sciences

PROJECT SUMMARY
This is a competing renewal application for a highly successful T32 program that has trained more than 180
predoctoral students in toxicology/environmental health sciences (EHS) over the last 45 years. The objective of
this predoctoral program is to train the next generation of environmental health scientists through interdisciplinary
research and coursework that address issues of direct relevance to the NIEHS mission. We are requesting 2
years of support for each of 8 predoctoral trainees beginning after their first or second year in a PhD degree
program. Trainees are recruited from several UC Davis graduate programs that provide disciplinary training
relevant to EHS, including toxicology, cell and molecular biology, exposure assessment, epidemiology,
neuroscience, immunology and genetics. Training faculty — 32 active researchers from 19 departments — have
substantial experience mentoring predoctoral students. Faculty research focuses on mechanisms by which
environmental factors contribute to human disease and encompasses diverse areas within EHS, including
respiratory toxicology, cancer, neurotoxicology, genotoxicity, epigenetics, and metabolic disorders. Significant
interactions between training faculty members promote interdisciplinary approaches to EHS research. Trainees
have access to advanced technologies, such as proteomics, epi/genomics and metabolomics, state-of-the-art
imaging, genetically modified organisms, and inhalation facilities for rodents and non-human primates. A strength
of EHS research at UC Davis is the vertical integration of studies directed toward understanding environmentally
induced disease. Molecular, cellular, tissue, and diverse animal models, including nonhuman primate models,
complement human clinical samples obtained through the UC Davis Clinical and Translational Science Center
(CTSC) and epidemiologic studies. The training program leverages the activities and resources of multiple
research centers at UC Davis to provide synergy and promote connections to disease prevention and public
health; examples include the NIEHS P30 Environmental Health Sciences Core Center at UC Davis, the MIND
Institute, Center for Children's Environmental Health, NCI Comprehensive Cancer Center, Western Center for
Agricultural Health and Safety, NIEHS Superfund Program and the NIEHS Center for Nanotechnology Health
Implications Research. The training program emphasizes practical instruction in scientific writing and
communication of scientific findings to peers and lay audiences through chalk talks, annual retreats, town halls,
and national meetings. Trainees are also exposed to emerging concepts, controversies, and technologies in
environmental health by participating in a trainee-organized and -managed seminar series that hosts leading
environmental health scientists from across the country, as well as through faculty–student interactions during a
summer course in which trainees explore a current issue relevant to environmental health under the guidance of
training faculty. Trainees will receive training in responsible conduct of research. The training program builds on
an excellent track record of training leaders in EHS in academia, government, and the private sector.

Public health relevance
PROJECT NARRATIVE The Advanced Training in Environmental Health Sciences program at UC Davis provides unique training in environmental health sciences (EHS) to predoctoral students to prepare them for diverse careers focused on the impacts of environmental factors on human health and disease. This program builds on existing interdisciplinary and collaborative research strengths at UC Davis, with vertical integration of studies at the molecular, cellular, organismal, and population levels directed toward understanding environmentally-induced disease. Funds are requested to provide 2 years of support for each of 8 predoctoral trainees who will receive a combination of didactic and experiential training to promote understanding of current and emerging concepts, controversies and technologies in environmental health, as well as a deep appreciation of responsible conduct of research, including rigor and reproducibility.